Disentangling the role of poverty-related experiences on children's self-regulation: Identifying dynamic and contextually-relevant mechanisms

PROJECT SUMMARY
Poverty-related adversities place children at an increased risk for developing behavioral self-regulation
difficulties that disrupt their capacity to learn and thrive across the lifespan. With nearly 12 million children
growing up in poverty in the United States, this represents a monumental public health concern. Clarifying the
environmental determinants and underlying mechanisms that explain associations between poverty and child
self-regulation skills is central for the creation of policies that address families’ challenges while leveraging
extant strengths. Several complementary theoretical frameworks of early life adversity suggest that the
accumulation of economic deprivation and psychosocial threat, and their corresponding patterns of
(un)predictability, shape distinct developmental mechanisms that prepare children to meet the demands of their
specific environments. This project bridges novel methodological and theoretical approaches to characterize
dynamic patterns of change in early-life experiences in the context of poverty, and examine the role such
experiences play in shaping children’s self-regulation in early childhood.
Early childhood is marked by substantial neurodevelopmental changes that support the emergence of
self-regulatory skills needed to meet the learning and psychosocial demands of schooling. Effects of poverty on
these developing regulatory systems are present as early as infancy, with more years spent at or below the
federal poverty line predicting greater self-regulation difficulties over time. Yet, how poverty leads to such
disparities remains largely unknown. The type, timing, and temporal variability in poverty-related experiences,
and their respective roles on contextually-adaptive self-regulation skills in early childhood, may be candidate
mechanisms underlying the effects of child poverty on long-term outcomes.
The current project addresses two aims using data from a large mixed-methods national survey
(N~13,000) of predominantly low-income families during the pandemic. Aim 1 will apply innovative
psychometric, time-series, and qualitative approaches to understand what, when, and for whom
poverty-related experiences are most salient (1a), as well as how and under which conditions such
experiences unfold (1b). Aim 2 will leverage quasi-experimental methods (i.e., propensity scores) to test the
putative impact of experiences revealed in Aim 1 on children’s emerging self-regulation skills as they transition
to formal schooling. Findings will afford novel and timely insights into the complex ways in which early
poverty-related experiences affect children’s ability to thrive, with broad implications for public health and
well-being during a monumental point in history that calls for much-needed policy reform. Under the guidance
of Sponsors Fisher, Obradovi?, and Frankenhuis, the proposed research and training plan will prepare the
applicant for a career as an independent researcher focused on the basic, translational, and applied study of
child poverty and self-regulation.

Public health relevance
With nearly 12 million children growing up in poverty in the United States, there is urgent importance in understanding the effects of poverty on children and families. Although many children flourish despite the stress that economic hardship brings, chronic and unpredictable poverty-related adversities put children at an increased risk of developing cognitive, emotional, and behavioral difficulties that, while potentially adaptive in the immediate context of poverty, may disrupt their capacity to meet the learning and psychosocial demands of formal schooling. Using data from a mixed-methods national survey of predominantly low-income families, the current project addresses central questions concerning (1) what, when, for whom, and how poverty-related experiences unfold during pivotal developmental periods; and (2) how such experiential manifestations enhance or impair core regulatory skills critical for children’s successful adaptation across contexts.